Production Assistance for Cellular Therapies (PACT)- Cell Processing Facilities- Cell manufacturing and process development services for PCT0027-01: Clinical Production of Viral Specific T Cell Lines

The overall objective is to manufacture and characterize a bank of T-cells specific for CMV, EBV, adenoviruses and BK virus (mVSTs).